HIV Drug Resistance in the New Antiretroviral Therapy Era in Kenya

HIV Drug Resistance in the New ART Era in Kenya Rami Kantor, MD
SUMMARY
Since the emergence of resistance to zidovudine in the late 1980’s, we have been in a race: an HIV drug is
developed and used, followed by the inevitable emergence of viral resistance to it, another drug is developed
and used, and so on. This largely resistance-driven process has informed antiretroviral drug development since
its inception. However, treatment monitoring, including drug resistance testing and at times viral load testing, are
limited in resource limited settings, where HIV burden is greatest, creating the global paradox: we test for and
know less about HIV drug resistance in locations where our understanding of it is most crucial. Such settings
may be more prone for resistance due to restricted monitoring in clinical care, higher treatment failure thresholds,
limited availability of advanced medications and formulations, circulating diverse HIV-1 subtypes, and special
circumstances like HIV-TB coinfection. Such situations might further enhance the risk to develop resistance and
exacerbate the complexity of addressing it. This paradox is even greater now that we are in the new global
antiretroviral therapy (ART) era. Remarkable progress in antiretrovirals like dolutegravir (DTG), with enhanced
efficacy, reduced toxicity, high barrier to resistance, and importantly, global accessibility, all instill a profound
confidence, suggesting that we may have achieved a pivotal milestone in the ongoing race against HIV. However,
the widespread utilization of DTG in all lines of ART, especially in settings with imperfect monitoring and limited
medication availability, raises concerns about continuing the drug resistance race. Emerging data confirm these
concerns and highlight research gaps related to resistance development to current era drugs and their magnitude
and consequences. This proposal is designed to address these gaps. Leveraging our long-standing North-
South collaboration, we propose to comprehensively and prospectively investigate the extent and impact of
transmitted and acquired resistance in a large HIV care program in Kenya, one of the earlier countries to enter
the new ART era in 2017. We hypothesize that the scale-up of DTG-based regimens across all lines of treatment
in resource limited settings is leading to a gradual escalation of drug resistance over time, impacting care. To
address this hypothesis, we will enroll and prospectively follow 1,840 Kenyan persons with HIV across the HIV,
ART and resistance timelines. We will characterize transmitted resistance (Aim 1) and investigate acquired
resistance (Aim 2) of 1st-line DTG-based ART (Aim 2a), 2nd-line ART (Aim 2b), beyond 2nd-line ART (Aim
2c), and special populations (Aim 3). Our understanding of resistance development in the new ART era is
limited, yet crucial to ensure its sustainable success. This timely Proposal will generate hypothesis-driven data
to address existing gaps and inform patient care towards ending the HIV epidemic. We expect to have a high
and direct impact on guiding future ART strategies to minimize resistance. The new ART era has been rolled out
for ~5 years, providing a unique opportunity to conduct this research. The right time to comprehensively
investigate resistance in the new ART era is now, to ensure that we don’t lose the race, in Kenya and beyond.

Public health relevance
HIV Drug Resistance in the New ART Era in Kenya Rami Kantor, MD NARRATIVE This Proposal aims to thoroughly study drug resistance in people with HIV in a large healthcare program in western Kenya, at a time when new and improved medications are being widely introduced for HIV treatment. This approach will enable us to study the expected rise in development of resistance to these medications over time, and gain insights on how to improve patient care and address the increasing global challenge of HIV drug resistance in the era of new HIV therapy.